DEVELOPMENTAL FUNDS

Over the past funding period Development Funds were allocated primarily in support of new faculty recruitment, pilot projects, and to a lesser extent development of new shared resources. Funds in this category in the CCSG were limited to approximately $200K per year due to budgetary constraints following the last re-competition. Developmental funds and AECC resources, in general, were targeted to address areas of concern identified at the last CCSG review and areas assigned high priority by the senior leadership based upon the outcome of the Center's internal and external review processes. Over the past funding period a total of $1.21M was allocated to Developmental Funds from the CCSG. Of this, 38% was allocated to New Investigator Support, 37% for Pilot Projects, and 25% for New Shared Resources. There will be considerable opportunities for AECC faculty recruitment and pilot project funding that will accompany the opening of the new Michael F. Price Center for Genetic and Translational Medicine over the next funding period. There are developing shared resources that will be targeted for Developmental funds. It is anticipated that 40% of Developmental Funds will be utilized for faculty recruitment, 40% for pilot projects, and 20% for new shared resources. In this application $250,000 is requested in year one for Developmental Funds.